Non-human primate MHC and KIR Allele Discovery and Typing Technology Development

The objective of this program is to discover new NHP MHC Class I, MHC Class II, Killer-cell Immunoglobulin like Receptor (KIR), and Fc Receptor (FcR) genes, loci, and alleles; develop genotyping technologies that will remain freely accessible to the NHP research community; provide all sequences generated to the NIAID-designated, publicly available databases. Other important goals are to: i) develop and apply whole genome/whole exome sequencing (WGS, WES respectively) to the MHC, KIR, and FcR regions; and ii) generate and make publicly available supplemental information, including: a) primer and probe definitions used in gene/allele discovery or genotyping; and b) familial relationships of animals used in gene discovery and allele frequency studies. This information will support the development and interpretation of transplantation and other studies in the NHP pre-clinical model